NATURAL HISTORY OF IDDM NEUROPATHY

Cross section and longitudinal epidemiologic studies of diabetic pts in Rochester, MN, are being conducted to determine the prevalence, characteristics and risk factors for development of diabetic neuropathy.